TRANSCRIPTIONAL LATENCY IN PEDIATRIC HIV INFECTION

The objective of this research is to determine the feasibility of detecting short and long transcripts in subjects known to be vertically HIV infected using a pre-selected blood volume which would be acceptable in most subjects regardless of age and size.